Lymphatic Support of Neurogenesis and Regeneration

PROJECT SUMMARY
The lymphatic vasculature plays a critical role in fluid homeostasis, removing cellular waste and immune
responses. Recent research has highlighted its integral contribution during the regenerative response after
cardiac injury. The central nervous system was until recently, believed to be immune privileged and lacking a
lymphatic system. Recent studies have revealed the lymphatic system extends into the mammalian and
zebrafish brain, however the role it plays in neurogenesis and the response to injury is unknown. The need to
better understand how to alleviate the detrimental responses to Traumatic brain injury (TBI) and stroke and
promote regeneration is imperative in order to improve outcomes. This proposal aims to uncover the different
populations of meningeal lymphatic system and brain endothelial cells and study how these contribute to adult
neurogenesis and regeneration.
Previously, we have characterized the development of the zebrafish cardiac lymphatic system and
identified the signaling pathways that regulate its specification and formation. We then demonstrated that the
cardiac lymphatic vasculature expands post injury in the adult zebrafish heart. This work demonstrated that
lymphatic vessels respond to injury and aid the regenerative response by trafficking immune cells. By blocking
lymphangiogenesis we demonstrated that the lymphatic vasculature was required to promote regeneration and
prevent scarring of heart tissue. The discovery of the meningeal lymphatics led us to hypothesize that
meningeal and brain lymphatics are made up of different and changing sub-populations that uniquely
support adult neurogenesis and regenerative repair after injury by providing neurotropic factors,
controlling cerebral spinal fluid (CSF) composition and the immune response.
To test this hypothesis, we will pursue transcriptional profiling in the zebrafish as a model of adult
neurogenesis and brain regeneration. We will characterize the different populations of lymphatic endothelial cells
and their response to injury using single-cell RNA sequencing analysis of meningeal lymphatic endothelial cells
and brain lymphatic endothelial cells from uninjured and regenerating brains. We will generate tools to allow
individual disruption of the lymphatic system components and test the impact of these on adult neurogenesis.
Pursuit of this will open new avenues for investigation of lymphatic support of neurogenesis in mammalian
systems in health and after injury. In order to further our comprehension of adult neurogenesis, the regenerative
response of the nervous system and potential therapies for which it is critical to understand the how the lymphatic
system modulates the immune and environmental aspects of neurogenesis and regeneration.

Public health relevance
PROJECT NARRATIVE Understanding the regenerative response of the nervous system in models that naturally regenerate is integral to the development of potential therapies for traumatic brain injury and stroke. This proposed study in zebrafish seeks to investigate the mechanisms through which meningeal and brain lymphatics contribute to adult neurogenesis and regeneration of the nervous system by characterizing these endothelial populations and generating tools to study them. Through these studies we will gain novel insights into the mechanisms that underpin the relationship between the lymphatic system and promoting the regenerative response of the central nervous system.